Human natural killer cells: Advancing biology and clinical applications

PROJECT SUMMARY
The current R35 competitive renewal is revised from 2023 (Score 15). The Panel and Reviewers raised 5 “minor”
(the word used in the Summary Statement) weaknesses that I addressed. I have studied the basic biology of
human natural killer (NK) cells and their clinical application for cancer treatment over the past 33 years. Basic
discoveries from my lab have brought chimeric antigen receptor (CAR) NK cells into the clinic, yet their
development for cancer treatment requires improvement. This proposal is built upon our body of work that has
been accomplished during the past seven-plus years of this R35 award. We investigated how NK cells develop,
survive, kill, and what cell-extrinsic or cell-intrinsic modifications are engaged to enhance these and other
properties to improve their clinical efficacy for cancer treatment. This resulted in over 50 publications, including
senior authorships in high-profile journals such as Cell, Nature Biotechnology, Nature Immunology (3), Nature
Cancer, Immunity (3), Science Immunology, and Cancer Discovery (2). Importantly, we successfully translated
our findings into the clinic to treat cancer patients. We now propose to address the key challenges in the field
and to improve CAR NK cell therapy. We will: (1) determine the biomarkers and mechanisms that will define
NK cell exhaustion, including in vivo models, to reduce or eliminate this effect; (2) investigate whether NK cells
possess memory of tumors and if tumors possess memory of NK cells. We will employ novel approaches to
define this at the molecular level; (3) elucidate mechanisms by which CAR NK cells traffic into solid tumors;
(4) optimize CAR constructs of NK cells for effective anti-tumor activity: and (5) perform IND-enabling studies
on CAR NK cells expressing IL-15 to then translate our discoveries into the clinic. This will be exemplified by
the proposed IND-enabling studies to translate our published work on anti-PSCA CAR NK cells expressing
soluble IL-15 from the past funding cycle (Teng et al., Gastroenterology, 2022) into the clinic to treat pancreatic
cancer (PC) patients via institutional funding sources. PC has a 5-year survival rate of 9% and is the 3rd leading
cause of cancer-related death. We believe our proposed studies for the next funding cycle will lead to
innovative, cost effective, allogeneic, “off-the-shelf”, and safe CAR NK cell therapies to benefit a broader group
of cancer patients.

Public health relevance
PROJECT NARRATIVE Natural killer (NK) cells, or innate lymphoid cells in general, are distinct from T cells. Due to their excellent safety profile and allogenic, off-the-shelf features, engineered NK cells (e.g., with a CAR and IL-15) are becoming attractive in the field of immune cellular therapy. In this revised R35 competitive renewal, we propose to advance knowledge and meet challenges in the field to improve NK cell-based therapy to treat a broader group of cancer patients by investigating NK cell exhaustion, determining if NK cells possess memory against tumors, enhancing NK cell trafficking into solid tumors, optimizing their cellular and molecular features, thereby improving NK cells for clinical translation.